The ADEPT Study: Estimating Prognosis in Advanced Dementia

DESCRIPTION (provided by applicant): Advanced dementia is a common, morbid and costly condition. The current standard of palliative care provided to the growing number of Americans dying with dementia is sub-optimal. The challenge of accurately estimating the life expectancy in advanced dementia is a major barrier to providing this care. Prognostication is needed to inform clinical decision-making and to access the Medicare hospice benefit. Hospice grossly under-serves persons with dementia largely due to difficulties predicting six-month survival. Current hospice eligibility guidelines for dementia are not based on empircally derived prognostic measures, and therefore completely fail to accurately estimate survival. Thus, the over-riding goal of the ADEPT study is to create a valid and practical risk score, the Advanced DEmentia Prognostic Tool, which will identify persons with advanced dementia at a high risk of death. To accomplish this goal, and building on the success of earlier work by the PI, we will develop the risk score using secondary data from a nationwide nursing home (NH) database, and then prospectively validate the score at the bedside. Our aims are: 1 To derive and validate a mortality risk score in a nationwide population of 237,783 NH residents with advanced dementia using 2002 Minimum Data Set (MDS) assessments;2. To compare the accuracy of the risk score to predict six-month survival with current hospice eligibility criteria for dementia using 2002 MDS assessments;3. To establish a cohort of 400 NH residents with advanced dementia and conduct a second, prospective validation of the mortality risk score to demonstrate that the tool is practical and effective at the bedside;and 4. To conduct a second, prospective comparison of the accuracy of the ADEPT risk score with hospice eligibility criteria for dementia. Implications: The proposed work to create a valid and practical instrument to estimate survival in advanced dementia, represents an opportunity to improve end-of-life decision-making and promote access to hospice services for the over 4.5 million Americans with dementia. The ADEPT instrument will also provide palliative care researchers with a method to identify subjects with advanced dementia at high mortality risk. Thus, the information derived from this study has the potential to make important clinical, research and policy-relevant contributions to the care of older persons with dementia at the end-of-life.